Development of Oncolytic Reovirus for Triple-Negative Breast Cancer

The objective of this proposal is to identify viral and host factors that promote reovirus infection and cell killing of TNBC cells and identify small molecule inhibitors that can augment viral-mediated killing of cancer cells. In the U.S., breast cancer is the leading cause of cancer and a leading cause of cancer-related deaths in women. Mammalian orthoreovirus (reovirus) is a segmented, nonenveloped dsRNA virus that predominantly infects transformed cells and is in Phase I-III clinical trials to assess its efficacy as a viral oncolytic against several cancers. Preliminary data indicate that serotype 1 reoviruses induce more efficient TNBC cell death than serotype 3 reoviruses and that cell death occurs via a caspase 3-independent pathway. RNA sequencing showed that IL-24 is highly upregulated during reovirus infection of TNBC cells and high-throughput screening identified topoisomerase inhibitors (doxorubicin, epirubicin, etoposide, and topotecan) that when paired with reovirus promote efficacious TNBC cell death. The central hypothesis is that reovirus infection with serotype 1 reoviruses in the presence of topoisomerase inhibitors induces complementary signaling pathways that result in TNBC cell death. Two integrated specific aims are proposed. Specific Aim 1 will elucidate mechanisms of reovirus-induced cell death of triple-negative breast cancer cells. Specific Aim 2 will determine how topoisomerase inhibitors impact reovirus infection. These experiments will enhance an understanding of the mechanism viruses use to kill cancer cells, define how combinatorial virus and small molecule inhibitor regimens impact viral infection, and inform the development of personalized therapeutic options for patients afflicted with TNBC.

Public health relevance
The objective of this proposal is to identify viral and host factors that promote reovirus killing of triple-negative breast cancer cells and define how DNA-damaging topoisomerase inhibitors impact reovirus biology. Based on preliminary data, we hypothesize that serotype 1 reovirus infection in the presence of topoisomerase inhibitors induces complementary cell death pathways that synergizes viral-mediated triple-negative breast cancer cell death. Knowledge gained from experiments in this proposal will enhance our understanding of how viruses promote cell death and illuminate the development of combinatorial therapeutics against triple-negative breast cancer.